Remote Patient Monitoring of Chronic Disease in Community Health Centers (REDUCE)

PROJECT SUMMARY/ABSTRACT: Clinical trial research has demonstrated that remote patient
monitoring (RPM) of chronic disease status can be an effective tool to achieve better control of blood
pressure and blood glucose for some populations such as participants in clinical trials and affluent patients.
However, little is known though about the effectiveness of RPM in healthcare delivery settings, or in
medically underserved populations. The Covid-19 pandemic has brought to the fore the important role that
RPM can play in ensuring continuity of care. It also has illustrated the limited infrastructural preparedness of
community health centers, which provide care to the most medically underserved patients in the U.S., to
provide RPM tools. The proposed study will evaluate the implementation of RPM tools to community health
centers for patients with hypertension and type 2 diabetes during the Covid-19 pandemic. The goal of this
study is to evaluate the biomedical effects of these RPM interventions, and to gain insights into barriers and
facilitators to implementation and adoption of the programs. Our results will inform efforts to ensure that
patients in community health centers can benefit from digital RPM interventions and will lay the foundation
for large-scale implementation of such interventions.

Public health relevance
PROJECT NARRATIVE New health care technologies can help patients who have chronic diseases take important health measurements, like blood pressure, at home, and share their results with their doctors. But we do not yet know whether using these technologies can improve the health of low-income patients, or how to effectively introduce them as part of everyday clinical care. We will answer these questions by studying a program that recently provided these technologies to patients at community health centers.